Translational Development of a Small Molecule for the Treatment of HBV Infection

ABSTRACT
Chronic Hepatitis B virus (HBV) infection remains a substantial global public health burden despite the availability
of vaccines and antiviral therapies, impacting approximately 300 million individuals worldwide. The virus infects
hepatocytes, leading to significant morbidity and mortality implications, including increased risks of cirrhosis, liver
failure, and hepatocellular carcinoma. Organizations such as the World Health Organization (WHO) and the
National Institutes of Health (NIH) aspire to develop a cure for HBV, projected to save thousands of lives and
reduce economic burdens associated with liver transplants and chronic disease management.
A key challenge to curing chronic HBV infection is the persistence of an independent, viral, covalently closed
circular DNA (cccDNA) minichromosome in the nucleus of infected hepatocytes, which serves as a reservoir for
ongoing viral replication and viral antigen expression. Current antiviral therapies, such as nucleos(t)ide reverse
transcriptase inhibitors (NAs) and Interferon-α (IFN-α), are inadequate to eliminate cccDNA or reduce viral
antigenemia, leading to viral rebound and drug resistance. There is urgency for novel therapeutic approaches
targeting HBV cccDNA longevity and/or transcriptional activities that will help clear chronic infection.
This STTR application brings together experts in HBV molecular biology and antiviral discovery to advance the
development of a novel small molecule therapeutic intervention. Through collaborative efforts including
laboratory research, analytical method development, formulation and preclinical studies, this project will validate
the proposed drug target, Hepatitis B X regulatory protein (HBx), a multifunctional critical player in HBV cccDNA
epigenetics and transcription. Our preliminary in vitro studies demonstrate concentration-dependent inhibition of
HBx-mediated depletion of SMC5/6 (a well-acknowledged cellular silencer of cccDNA) and suppression of
cccDNA transcription in HBV-infected cells, supporting the prospect of a new drug class. Our Phase I project
comprises two specific aims: (1) in vitro characterization of antiviral activities associated with targeting HBx and
cccDNA in multiple cell models to discern the implications of potential viral clearance mechanisms, and (2) in
vivo pharmacokinetic and pharmacodynamic studies in a rodent model to optimize drug formulation and dosing
routes that support safe and effective drug delivery to target liver tissues. Successful completion of these aims
will enable subsequent proof-of-concept Phase II HBV-infected humanized mouse model studies and advance
preclinical development for IND-enabling milestones toward clinical testing. This project enables an innovative
therapeutic approach − defined as a high strategic priority by both the NIH and the WHO − to develop curative
therapies for chronic HBV infection, which could significantly impact public health outcomes and reduce the
global burden of this disease.

Public health relevance
Project Narrative Chronic hepatitis B virus (HBV) infection affects ~300 million people globally (1.6 million U.S.), and is a leading cause of hepatocellular carcinoma, liver failure, cirrhosis, and mortality. This project seeks to develop a lead small molecule demonstrating reductions of persistent sources of virus that could lead to a curative therapeutic strategy for chronic HBV infection. A cure for HBV is a strategic priority for the National Institutes of Health.